CHILD MEDICAL CENTER TV VIEWING EVALUATION IN CHILDREN

The first phase of this study will define the demographics of the viewing audience of each of the three live broadcasts of CMC-TV, closed-circuit television at the U.VA. Children's Medical Center. During the second phase of this study, evidence will be gathered on the relationship of participation in the closed-circuit television project to the children's health self-concept, participation in educational and recreational activities, and general emotional state.